Administrative Core

PROJECT SUMMARY - Administrative Core
The Administrative Core will contribute to the overall goals of the Chicago Center for Diabetes Translation
Research (CCDTR): 1) Provide core resources in Intervention Design and Implementation Science; Research
Design, Data, and Analytics; Community Engagement and Health Equity; Accelerating Health Equity And
Eliminating Diabetes Disparities in Community Health Centers (AHEAD-CHC) that catalyze and support
innovative, rigorous translational research to advance health equity for the prevention and management of
diabetes. 2) Increase the impact of rigorous diabetes translational research to reduce disparities in Chicago
and the nation by organizing partnerships across academic institutions and stakeholder groups into working
groups that include: Clinician-Patient Relationship and Shared Decision Making, Social Determinants of
Health, Diabetes Prevention, Diabetes Modeling, Organization and Financing of Care, Diabetes and Aging. 3)
Attract and support diverse investigators who are new to the area of diabetes translational research by
providing education, training, mentoring, support for community and stakeholder engagement, pilot and
feasibility seed grants, and access to critical translational research core resources.
The Center is composed of 3 Translational Research Methods Cores (Intervention Design and
Implementation Science; Research Design, Data, and Analytics; Community Engagement and Health Equity),
an Enrichment Core, a Pilot and Feasibility Grant Program, and a Regional/National Resource Core for
“Accelerating Health Equity And Eliminating Diabetes Disparities in Community Health Centers
(AHEAD-CHC).” 6 Working Groups help organize the diabetes translation researchers into collaborative
groups to facilitate projects and access of members to mentorship, assistance, and partnership. A weekly
Center-wide Zoom Research-in-Progress conference will be a key feature that will bind the Center
members together into an active, engaging community of diabetes translation researchers working on
important problems together and helping each other. The Administrative Core oversees the entire Center.
The Administrative Core is composed of the Center Co-Directors and the Co-Directors of the 3 Translational
Research Methods Cores, the Enrichment Core, and Pilot and Feasibility Program.
The Specific Aims of the Administrative Core are to:
1) Ensure that the Center catalyzes and supports innovative and rigorous translational research to advance
health equity for the prevention and management of diabetes in Chicago and nationally.
2) Oversee all Center operations, the translational research cores, and website.
3) Oversee the Enrichment Program and Pilot and Feasibility Program.